RECORD-LINKING SYSTEM FOR GENETICS AND EPIDEMIOLOGY

A wide range of genetic and epidemiologic studies rely on linking records in separate files which refer to the same individual. The purpose of this proposal is to design and begin implementation a prototype of a system which facilitates linking records where the identifying information between records is not identical. Although a general theory of record linking has evolved over the last several decades, no general system exists which allows record linking of data sets to be done without an extensive ad-hoc programming effort. This project will demonstrate a record linking system which is integrated with a database management system and allows record linking projects to be performed without the user being involved in details of data management. During Phase I, we will (1) design the user interface for the record linking system and (2) implement a prototype of part of the system focusing on the steps of scoring and choosing final links. We will utilize social security records and death certificates from California as a test bed for the system. These records were used as part of an earlier project and both intermediate results and "true" links are available for comparison with results obtained with the new system.